Immune and genetic controls of tissue regeneration in mice and humans

Humans generally heal skin injuries with a fibrous scar, which results in increased skin tightness,
altered cosmesis, and morbidity when scars form over joints. Under specific and rare circumstances, humans
and mammals exhibit spontaneous tissue regeneration, which heals tissue to their original architecture and
function without a scar. Thus, the molecular machinery for tissue regeneration exists in mammals and
understanding how to elicit regeneration will help us attain our long-term goal of regenerating injured human
skin. Prior work from our group and others used ear hole closure to demonstrate that “regeneration-competent”
mouse strains, including p21–/–, wildtype aged, and skin-specific CXCL12–/– mice, close ear holes to ~90% of
the wounded size compared to control mice, which close holes to ~50%. Despite this improved healing, only
1% of regeneration-competent mice achieved complete ear hole closure. During the past funding cycle, we
increased the frequency of complete hole closure, and most recently showed that topical imiquimod activates
TRPA1+ neurons to drive complete ear hole closure in 20% of mice. This 20-fold improvement is substantial,
and we continue to aim higher. In our preliminary data, we performed single-cell RNA-sequencing on wound-
edge tissue from TRPA1+ activated and aged mice to identify signaling pathways driving tissue regeneration.
Ligand-receptor interaction analysis identified a new receptor-mediated signaling pathway that promotes tissue
regeneration. Unexpectedly, mice lacking this receptor exhibited the opposite phenotype; they demonstrated
faster wound closure, decreased scar formation, and improved tissue regeneration in 3 different skin injury
models. However, topical imiquimod treatment synergizes with receptor deficient mice to increase the
frequency of complete ear hole closure to 90%. Taken together, we conclude that this newly identified receptor
regulates both speed and quality of wound repair, which counters the current paradigm that the speed of
wound closure and quality of wound healing are inversely related. Moreover, this pathway is independent from
TRPA1+ neurons to promote regeneration. We hypothesize that this receptor pathway promotes scar
formation and blocking this receptor permits tissue regeneration. In Aim 1, we elucidate the molecular
mechanism of how this receptor promotes scar formation. We will use mouse genetics and our injury models to
identify which cell types expressing this receptor are necessary and sufficient to drive scar formation. Next, we
will use mouse genetics and pharmacologic inhibitors to identify the molecular mechanisms downstream of the
receptor that promote scar formation. In Aim 2, a major gap in the wound healing field is the limited
understanding of human wound healing due to sample availability. To fill this gap, we created the infrastructure
to collect human skin in a dense time course after injury for single-cell RNA-sequencing. We expect increased
recruitment of cells expressing our receptor to the injury site, and we will compare transcriptomic changes
against our mouse dataset. Importantly, this dataset will be a resource for all wound healing researchers.
Finally, we will translate our 90% complete ear hole closure finding into human skin. We hypothesize that
combination small molecule mediated inhibition of our receptor and topical imiquimod will reduce scar
formation in human skin. We will test this possibility by using human orthotopic skin xenografts on immune-
deficient mice. If successful, this data may serve as the pre-clinical foundation for a future clinical trial. Taken
together, we continue to improve our understanding of eliciting scarless wound healing and actively translate
our findings into humans, which is applicable to all Veterans living with traumatic or surgically-created wounds.

Public health relevance
Cutaneous wounds create significant health problems for Veterans, including wartime trauma, diabetic foot ulcers, and pressure ulcers. More than 100 million new skin wounds appear annually on patients, and most skin wounds heal with a fibrotic scar. Scars themselves may also cause severe emotional distress, skin tightening, and physical disability. Although many products are marketed for scar prevention or removal, their results are modest. We aim to develop new therapeutic approaches to tissue repair based upon a deep understanding of the molecular mechanism and a firm commitment to the clinical/translational mission. In our preliminary data, we discovered that the deletion of a cell surface receptor increases the efficiency to induce scarless wound healing in mouse skin. We will dissect molecularly how this receptor regulates scarless wound healing and test whether blocking this receptor also promotes scarless wound healing in human skin.